Evolution of Cargo Transport

Transporting cellular cargo with spatial and temporal precision is critical for many processes in all cells. Different
cell types and organisms use diverse machineries for long-distance cargo transport. For example, mammalian
cells and many filamentous fungi transport cargo using the microtubule-based motors dynein and kinesin, while
yeast use myosin motors on actin cytoskeleton tracks. Despite a general understanding of cellular transport and
the motors involved, little is known about how similar transport machineries are adapted by specific cell types or
organisms. Dr. Christensen’s current research investigates canonical (motor-driven) and non-canonical cargo
transport. In this proposal, she will investigate how both modes of transport have evolved in different organisms
using an innovative approach in which evolutionary hypotheses are directly tested using comparative cell biology
in fungal and mammalian cells. Defects in transport are particularly prevalent in neurological disorders such as
Alzheimer’s, Huntington’s and ALS. Examining how diverse cell types differently use the transport machinery is
directly applicable to understanding how transport defects lead to cell-specific diseases.
In Aim 1, Dr. Christensen will investigate how regulators of motor-driven transport have evolved in fungi
and human cells. In her current research and the K99 phase of this award, she will investigate how the gene
expansion and functional diversification of the ‘FHF’ protein complex allows dynein to bind multiple cargos in
human cells. For the R00 phase of this award, Dr. Christensen will identify and characterize novel dynein
regulators using evolutionary analysis and comparative cell biology in A. nidulans and human cells.
In Aim 2, Dr. Christensen will investigate a non-canonical form of transport known as ‘hitchhiking’. In
hitchhiking, a cargo attaches to and is co-transported with another cargo to achieve motility. Hitchhiking has
been demonstrated to occur in two evolutionarily divergent species of filamentous fungi, Aspergillus nidulans
and Ustilago maydis. In the K99 phase of this award, she will investigate a potential evolutionary advantage of
peroxisome hitchhiking in A. nidulans and determine if mRNA hitchhiking convergently evolved in A. nidulans
and U. maydis. In the R00 phase of this award, she will determine if hitchhiking occurs in a third filamentous
fungus, Ashbya gossypiii, a fungus lacking canonical microtubule-based transport.
Dr. Christensen’s goal is to develop an independent research program at the interface of cell and
evolutionary biology. To accomplish this, she will attend conferences spanning fields and participate in UCSD-
sponsored and MOSAIC UE5 initiatives focused on lab management and the transition to independence. She
will receive guidance from her mentoring committee (faculty listed below) and her primary mentor, Sam Reck-
Peterson. This development plan, combined with training in evolutionary biology (with Matt Daugherty, UCSD),
mammalian cell vesicle trafficking assays (with Susan Ferro-Novick, UCSD), and A. gossypii (with Amy
Gladfelter, UNC Chapel Hill) will prepare her to excel in an independent position.

Public health relevance
PROJECT NARRATIVE In the cell, many different cargos must be transported with spatial and temporal precision, and defects in intracellular transport are prevalent in many neurological disorders. There is an incredible diversity of cellular transport behavior and modalities in nature—how do different cells transport cargo, and how do they adapt the transport machinery for their specific needs? This proposal will investigate the evolution of different modes of cargo transport.